Investigation of the role of TET proteins in epigenetic reprogramming and establishment of germline imprinting

Project abstract:
Genomic imprinting is a form of epigenetic regulation that restricts expression of a critical subset of genes to
one parental allele. Imprinted gene expression is primarily regulated by differential methylation, which is
acquired during gametogenesis, between the two parental alleles on cis-acting elements known as imprinting
control regions (ICRs). Asymmetric patterns of active or repressive histone tail post-translational modifications
(PTMs) further reinforce the monoallelic expression of imprinted loci. In humans, abnormal expression of
imprinted genes is associated with imprinting disorders such as Beckwith-Wiedemann and Prader-Willi
syndromes. Methylation at ICRs is stable throughout development and is only dynamically modulated during
primordial germ cell (PGC) development and gametogenesis. In mammals, PGCs are derived from the somatic
epiblast and undergo epigenome reprogramming in order to: 1) prevent the transmission of gestationally
acquired epimutations to the next generation and 2) erase the parentally-inherited somatic imprinting marks to
allow for the acquisition of new imprints that are consistent with the sex of the embryo. Previous work from our
laboratory and others have implicated the role of TET1, a methylcytosine dioxygenase, in the establishment of
proper imprinting marks in the mature male and female gametes. My preliminary data suggest that while TET1
is necessary for complete methylation erasure of a subset of ICRs in PGCs, it also plays a previously
unexplored role of protecting paternally methylated ICRs from gaining ectopic methylation in the oocytes. As
TET1 is a large protein with the ability to interact with and influence activities of various chromatin remodelers,
I hypothesize a novel non-catalytic role for TET1 in promoting the proper establishment of germline imprints by
remodeling the broader chromatin landscape of ICRs. The objective of this proposal is to investigate how the
remodeled chromatin landscape of ICRs in PGC development contributes to the proper acquisition of sex-
specific DNA methylation patterns during oogenesis. In Aim 1, I will test the hypothesis that TET1 facilitates
chromatin remodeling of the ICRs during methylation erasure in PGCs. I will use allele-specific cleavage under
targets and release using nuclease (CUT&RUN) to assess the efficiency of chromatin reprogramming in Tet1-/-
hybrid PGCs. In Aim 2, I will identify loci, in addition to paternally methylated ICRs, which ectopically gain
methylation during oogenesis in absence of TET1. To investigate the mechanism underlying ectopic de novo
methylation in Tet1-/- oocytes, I will investigate the status of histone PTMs that are associated with DNA
methyltransferase-resistant chromatin landscape at paternally methylated ICRs in Tet1-/- oocytes using
CUT&RUN. Collectively, this proposal will elucidate the catalytic and non-catalytic functions of TET1 in the
establishment of the proper chromatin landscape at ICRs and the correct acquisition of germline imprints.
Mechanistic studies of germline imprinting establishment will enhance our comprehension of the molecular
requirements for high quality gametes, as well as etiology of human imprinting disorders.

Public health relevance
Project narrative: Errors in the establishment of epigenetic imprinting marks in the parental gametes may result in compromised embryonic development and various congenital imprinting disorders. The proposed work aims to determine the catalytic and non-catalytic roles of TET proteins in facilitating the proper acquisition of imprinted marks throughout gamete development. Specifically, experiments herein seek to uncover the molecular mechanisms that protect against ectopic imprint acquisition in the developing oocytes.